A Family Genetic Study of Autism and Fragile X Syndrome

Project Summary
Pragmatic (i.e., social) language impairments are a defining feature of autism spectrum disorder (ASD) that
impose a significant burden on individuals throughout their lifespan. Strong evidence suggests that pragmatic
language differences aggregate subclinically among first-degree relatives, reflecting the broad autism phenotype
(BAP), and have been linked to variation in FMR1, a highly penetrant ASD risk gene that causes fragile X
syndrome (FXS) and a constellation of clinical and neuropsychological phenotypes among women who carry the
FMR1 gene in its premutation (PM) state. In the prior award period, we demonstrated striking parallels in
pragmatic-related skills in the BAP and FMR1 PM, as well as important phenotypic distinctions, which together
point toward highly specific ASD-related skills that appear tied to the FMR1 gene. In this renewal application, we
build on this work with an expanded, multidisciplinary team of investigators to apply innovative multi-layered
deep behavioral and neural phenotyping, building on our most promising findings, with an armamentarium of
cutting-edge, computationally-based analytic platforms to further delineate the mechanistic contributors to ASD-
related pragmatic profiles in individuals with FMR1 mutations (fragile X syndrome and the FMR1 premutation).
Delineating the molecular genetic underpinnings of ASD-related pragmatic skills is crucial for understanding the
etiology of the social communication clinical symptom domain of ASD, which may reveal biologically based
targets for intervention. In this project, we will characterize ASD-related pragmatic profiles that extend beyond
traditional, categorically defined diagnostic boundaries among individuals with FMR1 mutations, and how such
profiles may be linked with targeted neurophysiological signatures and molecular genetic variation. This project
will capitalize on extensive, comparable data collected from individuals with ASD and parents with and without
the broad autism phenotype (BAP), available through an active companion R01. Aim 1 will apply both
hypothesis- and data-driven analytic approaches to a comprehensive battery assessing component skills
contributing to ASD-related pragmatic profiles in individuals with an FMR1 mutation. Aim 2 will employ a battery
of targeted, multidimensional electrophysiological measures to examine potential neural correlates of pragmatic
profiles. Finally, Aim 3 will evaluate the relationship between behavioral and neural phenotypic signatures
obtained in Aims 1 and 2 and FMR1-related genetic variation. Results from the prior phase of this project and
new preliminary data strongly implicate a complex network of skills contributing to ASD-related pragmatic profiles
among individuals with a FMR1 mutation that may be sensitively measured with the advanced fine-grained
computational- and machine-learning-based approaches proposed, with compelling ties to neurophysiological
and molecular genetic correlates that will be measured. The data produced will further the understanding of
clinical heterogeneity in ASD and the mechanistic origins of the pragmatic language clinical domain, and produce
phenotypes with translational potential for application in clinical trials, interventions, and treatment.

Public health relevance
Project Narrative The proposed competing renewal brings together basic, translational, computational, and clinical investigators to support critical research on the role of the FMR1 gene (a strong candidate gene linked to autism spectrum disorder (ASD)) and pragmatics, the social language skills that are most profoundly affected in ASD. We examine pragmatic language profiles, and potential neural correlates, that extend beyond traditional diagnostic boundaries to show overlap in ASD and individuals who carry mutations in the FMR1 gene, and how such traits are linked to molecular-genetic variation. Study aims will generate findings, resources, and tools that will lead to improved understanding of the etiology and mechanistic underpinnings of pragmatic impairments in ASD.